ApolipoproteinL1 Genotypes and Biomarkers of Immune Activation and Tubular Injury

PROJECT SUMMARY
Chronic Kidney Disease (CKD) can effectively be a death sentence in sub-Saharan Africa where <2% of
patients with kidney failure have access to dialysis or transplantation. Biomarkers of immune activation (soluble
tumor necrosis factor receptor 1 [sTNFR1], tumor necrosis factor alpha [TNFα], soluble urokinase
plasminogen activator receptor [suPAR]), and biomarkers of tubular injury (kidney injury molecule 1 [KIM-1]),
have been associated with CKD progression. However, few studies have investigated CKD biomarkers in
relation to APOL1 genotypes, and the findings in existing studies have been inconsistent. We do not know
whether there is subclinical evidence of tubular injury prior to decline in kidney function and how this differs for
high- vs low-risk APOL1 genotype carriers. Furthermore, we lack a clear understanding of how biomarkers of
immune activation may modify CKD progression in high-risk genotype carriers. We propose an R03 application
leveraging the Diet, CKD, and ApolipoproteinL1 (DCA) study which is an ancillary study to the Human
Hereditary and Health in Africa (H3Africa) kidney disease study. The DCA study has enrolled 738 individuals
with CKD in Nigeria and Ghana. DCA participants are being genotyped for APOL1 and have stored plasma
and 24hr-urine aliquots along with follow-up serum creatinine for estimated glomerular filtration rate (eGFR)
and CKD progression. Our overall hypothesis is that inflammation and tubular injury are key factors in the
development and progression of APOL1-mediated kidney disease; to test this hypothesis, we will measure
biomarkers of inflammation and tubular injury in Africans with CKD and compare across low-and high-risk
APOL1 genotypes. Our specific aims are to: 1) Determine the cross-sectional associations of KIM-1, a
biomarker of tubular injury, with APOL1 high- compared to low-risk genotypes; 2) Determine the prognostic
significance of inflammation biomarkers in Africans with CKD across high- and low-risk APOL1 genotypes. The
R03 project will add critical elements to the DCA cohort and provide the PI, Dr. Ilori, with preliminary data for
future R01 applications focused on validating findings in larger cohorts and in new studies recruiting Africans
with high-risk genotypes without CKD. Using genomic data and biomarker data to phenotype individuals with
subclinical and overt kidney disease will advance precision medicine in CKD and will add to the evidence base
on mechanisms of APOL1-mediated kidney disease.

Public health relevance
PROJECT NARRATIVE Inflammation and tubular injury are key factors in progression of APOL1- mediated chronic kidney disease (CKD). This research examines differences in tubular injury and inflammation biomarkers in APOL1- and non- APOL1 mediated CKD. This study will utilize novel CKD biomarkers and genomic data to advance the field of precision medicine in a population of Black individuals disproportionately affected by CKD.